Society for Birth Defects Research and Prevention Conferences 2024–2028

Project Summary Abstract
The Society for Birth Defects Research and Prevention (BDRP) will hold its 64h Annual Meeting at the
Wyndham Grand Pittsburgh Downtown, in Pittsburgh, PA—June 22–26, 2024. The scientific program covers a
wide range of cutting-edge research in birth defects and disorders of developmental origin. The 2024 session
topics include the role of the microbiome in development; the role of stem cells in research; the epidemiology
of congenital anomalies in minoritized populations; how to effectively communicate complex scientific
concepts; exposures and biochemical pathways that lead to adverse pregnancy outcomes; facial morphology
and dysmorphology; understanding the risks and mechanisms that underlie spina bifida; PFAS and placental
dysfunction; developmental neuropathology; and DART strategies for oligonucleotides. BDRP encourages
innovation in the field of birth defects research. Each year the abstract reviewers identify the abstracts that they
find innovative and provide their reasons to the Awards Committee, They select the top three innovative
abstracts to compete for the Innovator Award which recognizes innovative and translational research at the
intersection of at least two of the following areas: basic science, new technologies, clinical research, policy,
and outreach. Meeting attendees historically come from diverse professional backgrounds including basic and
clinical scientists from the academic, industrial, and government research sectors. The BDRP Annual Meeting
provides a unique forum where basic, clinical, and epidemiologic researchers come together to share progress
toward a common understanding of the causes and mechanisms of birth defects and developmental disorders,
and to translate these discoveries into clinical practice.
The Society strives to encourage, engage, and mentor students and new/early-stage investigators (trainees),
recognizing that its trainees represent the future of both the Society and the important scientific work
necessary to fulfill its mission to understand and prevent birth defects. Through the establishment of the
Diversity, Equity, Inclusion, and Accessibility Committee, BDRP is exploring how to recruit and mentor students
from under-represented and under-served populations. Specific events at the Annual Meeting encourage
trainee participation, including a career night to introduce trainees to members from different disciplines; and a
luncheon workshop highlighting professional development topics. Trainees are encouraged to present their
research; eight to ten trainees are invited to compete for the prestigious Wilson presentation award in a special
platform session, and all trainee poster presentations are judged for best poster presentation awards. Trainees
are also encouraged to serve as ad hoc members on Society committees, thereby deepening their involvement
within the Society. In this application, we are requesting funds to support Travel Awards for trainees to attend
the 2024–2028 Annual Meetings, and to partially support travel expenses of key nonmember speakers who will
help us educate and inspire these trainees.

Public health relevance
Project Narrative For 63 years, the Society for Birth Defects Research and Prevention (BDRP) has promoted basic and clinical research to understand the causes and mechanisms of birth defects, the potential effects of drug, chemical, infectious, or other exposures on the developing embryo/fetus, improve reproductive health, understand developmental origins of adult disease, and translate these discoveries into clinical practice. The Annual Meeting provides a forum for scientists, clinicians, and science policy regulators from academic, industrial, and government sectors to present cutting-edge research, exchange ideas and information, and engage in discussions among established experts in the field, new researchers, and students. The goals of the BDRP align with the goals of NICHD in advancing the knowledge on reproduction and embryo-fetal and postnatal development, as evidenced by the theme of the 2024 Annual Meeting, Addressing Disparities in Birth Defects Research and Prevention.